Role of the CD43 Receptor on Effector CD8+ T Cells During Acute Allograft Rejection

PROJECT SUMMARY
Despite excellent short-term outcomes after transplantation, the long-term survival of transplanted organs
has stagnated for several decades. Recent clinical studies have demonstrated that acute cellular rejection, which
is mediated by alloreactive T cells, is a risk factor for later graft failure. In order to effectively prevent acute
rejection, deeper understanding of how T cells response to allogeneic antigen are needed. The CD28 pathway
blocker belatacept (a CTLA-4 Ig derivative) offers significant long-term benefits versus calcineurin inhibitors for
kidney transplant patients, but has limited efficacy in restraining CD8+ T cells and acute cellular rejection. Despite
a great body of work investigating the programming of effector CD8+ T cells (TEFF) that respond to infections,
relatively little is known about CD8+ TEFF that respond to allogeneic antigen in the context of an allograft. We
found that after grafting, a subset of CD8+ TEFF expressing the activated CD43 isoform (defined by the 1B11
epitope) are formed during acute effector timepoints from day 7-21 post-graft. CD43 is a cellular receptor that
influences T cell receptor signaling cascades and cellular trafficking, but its role in transplantation is undefined.
Relative to other TEFF subsets, CD43+ TEFF appeared highly activated, displayed vigorous effector functions, and
drove accelerated graft rejection. In human renal transplant patients, CD43+ CD8+ T cells infiltrate the kidney
allografts of patients treated with belatacept, and CD43+ CD8+ T cells are functionally resistant to CTLA-4 Ig in
vitro. Together, these data form the premise for our hypothesis that CD43+ TEFF are a potent effector population
that can be targeted to limit acute rejection following transplantation. In this proposal, we will use an innovative
MHC Class I tetramer to characterize the role of CD43 on graft-specific CD8+ T cells. Specific Aims: First, we
will define the effector mechanisms that distinguish CD43+ TEFF function as a population from CD43- TEFF. Using
adoptive transfer approaches, we will investigate the differentiation pathways that lead from naïve CD8+ T cells
to CD43+ TEFF, the mechanisms by which CD43+ TEFF traffic from the draining lymph nodes into graft tissue, and
the role of the Inducible T Cell Costimulator (ICOS) receptor signaling in the fate of CD43+ TEFF. Second, we will
investigate the role of CD43 receptor signaling on CD8+ T cells. Using a CD43 knockout mouse model, we will
interrogate the requirement of CD43 signaling for graft rejection, how CD43 controls T cell at the clonal level,
and the role of CD43 in determining the quality of secondary memory responses. Third, we will explore the
potential of CD43 as a therapeutic target to limit alloimmunity in humans and mice. We will evaluate whether
targeted deletion of CD43+ TEFF in vivo with an antibody-drug conjugate can elicit tolerance in combination with
CD28 blockade. We will explore whether human CD43+ CD8+ T cells are a significant contributor to alloreactivity
and resistance to CD28 blockade. This proposal will generate deeper understanding of allogeneic TEFF that will
lead to new strategies to restrain CD8+ T cells that mediate acute rejection.

Public health relevance
PROJECT NARRATIVE Transplantation is a curative therapy for organ failure in many different diseases. Although acute rejection mediated by T cells is a significant contributor to the premature failure of grafted organs, there is limited understanding of how CD8+ T cells differentiate into effector populations after grafting. Greater understanding of the signaling pathways controlling the effector CD8+ T cells that reject allografts will lead to more targeted therapeutic strategies to improve graft survival.